Free energy-based active learning for ligand off-target and multitarget activity

Abstract
Small molecule kinase inhibitors are a class of targeted therapeutic anti-cancer agents that selectively target
specific kinases associated with a given cancer and are generally less toxic than general-purpose
chemotherapies. Due to the highly conserved nature of the ATP-binding domain, kinase inhibitor off-target activity
is often observed. This off-target activity can be beneficial--for instance, when the kinase inhibitor is active
against multiple drug targets--or it can be deleterious, leading to toxic side effects. Thus, knowledge of off-target
activity is essential during the early stages of the drug discovery pipeline; however, as experimental screening
is costly and time consuming, off-target activity is often only explored in the final stages of lead optimization.
Free energy-based in silico methods such as alchemical relative binding free energy (RBFE) simulations, which
are becoming prevalent in traditional single target drug discovery efforts, afford a cost-effective solution; but, to
date, no one has attempted their use for predicting off-target activity due to the cost and complexity of simulating
multiple protein-ligand complexes for many ligands. To address this shortcoming, we propose to combine novel
methods for reducing the computational expense of each simulation with multi-objective active learning to limit
the overall number of requisite simulations to explore a chemical space. In Aim 1, we propose a novel method
for the optimal stratification of the phase space for RBFE simulations to reduce computational expense while
maintaining requisite accuracy. Combined with our recently developed on-the-fly optimization method, we will
greatly reduce the computational cost of RBFE simulations. In Aims 2 and 3, we will combine these methods
with our group’s recently developed free energy-based active learning workflow implemented for multi-objective
optimization of ligand binding affinity within a chemical space, representing the first use of free energy-based
methods for the prediction of affinity to multiple proteins in a drug discovery setting. In Aim 2, we will utilize this
workflow to optimize ligands for selectivity to a kinase target and against activity of known off-target kinases. We
will test this workflow by targeting the activin-like receptor kinase 2, mutations of which are associated with the
fatal pediatric brainstem tumor diffuse intrinsic pontine glioma, while penalizing activity against other activin-like
receptor kinases. In Aim 3, we will utilize this workflow to optimize multikinase inhibitors for activity against
multiple known drug targets. We will test this workflow by optimizing the hit compound which led to the
development of the multikinase inhibitor Entrectinib against anaplastic lymphoma kinase, c-ros oncogene 1
kinase, and tropomyosin receptor kinases A-C. By demonstrating the feasibility of free energy-based multi-
objective optimization for affinity to and for selectivity over multiple kinases, we will greatly increase the efficiency
of the early drug development pipeline for targeted therapeutics.

Public health relevance
Project Narrative The discovery of selective mono and multikinase inhibitors is challenging due to the highly conserved ATP- binding domain and the costly and time-consuming nature of experimental screening. This work seeks to overcome these barriers through fast in silico molecular dynamics-based binding free energy simulations, utilizing novel optimization methods, combined with active learning machine learning for multi-objective optimization to identify potent inhibitors that are selective over known off-target kinases or are active against multiple known drug targets. By demonstrating the benefit of explicitly considering both off-target and multitarget activity early in the drug discovery pipeline, the speed and efficiency of anti-cancer agent discovery will be greatly increased.